Investigation of Protein-Protein Interactions in the ERAD Ubiquitylation Pathway

Our studies of the ubiquitin-ligase E3, called gp78, are conducted in collaboration with Dr. Allan Weissman, CCR. The gp78 protein has a role in sarcoma metastasis, and it is an excellent target for a combined structural and molecular biological investigation of mechanism and intervention. We have reported major findings from this project in a series of publications. The effort is an interdisciplinary effort involving molecular biology in the Weissman lab, NMR structural biology and biophysics in the Byrd lab, and X-ray crystallograpny in the Ji lab. These studies uncovered a new aspect of the E2:E3 interaction, wherein the action of a newly identified E2-binding site in gp78 results in an allosteric effect on the E2 Ube2g2 increasing the affinity for the gp78-RING finger domain by 50-fold. We also showed that the effect of the binding region (G2BR) is effective for other RING finger containing E3s (Mol. Cell). The generalization of this phenomenon is leading to a broader understanding of ubiquitination and shifting in the paradigm for the molecular mechanism of ubiquitin transfer. These studies have been extended in both the Weissman and Byrd labs. We published structural information on the ternary complex of the gp78-RING:Ube2g2:G2BR system from both NMR and crystallographic studies (EMBO J), and a related approach was undertaken for a different E2:E3 pair and published in Molecular Cell. We have examined the solution structure of the CUE domain, which is a distinct functional domain within gp78, and its interactions with ubiquitin and di-ubiquitin. These results were published in Structure. We are continuing our examination of the detailed interactions and mechanism of ubiquitin transfer. Another aspect of this system is the role of dynamics in determining chain linking specificity. We are employing NMR methods to directly correlate molecular motions/dynamics of regions of the Ube2g2 enzyme with the pertinent interactions to domains of gp78. These data will be critical to developing an overview of the reaction cycle for ubiquitin loading, transfer, and chain specificity. We have added the use of small-angle X-ray scattering (SAXS), conducted on protein complexes in solution, to enable us to examine larger constructs of the ubiquitination machinery. We have also developed a membrane mimetic which will enable the extension of these studies to the membrane surface. These efforts will continue for the next year. Current efforts also involve understanding the role of conformational dynamics via both experimental NMR and computational (molecular dynamics) methods to provide molecular insight to the allosteric mechanisms (published in Structure 2017 and methods developments in 2016-2020). We are also investigating the positioning and dynamics of the ligated ubiquitin in the context of E2Ub and E3:E2Ub complexes. Our efforts are expanding to include the use of NMR-derived conformational dynamics to understand allosteric mechanisms. Current developments are enabling us to examine the complete gp78C system in complex with the E2 Ube2g2 using our developed segmental engineering and labeling approaches. We are also examining further specificity identified in the Weissman laboratory regarding E2 recognition by complimentary E3 proteins. This year (2021) an extension of the concepts found in this work have led to a publication in PLoS Biology that illustrates a related allosteric binding partner for E2 enzymes. This new protein, AUP1, provides the means to dissect the allosteric selection and activation of E2:E3 pairs and will lead to further understanding of recognition and specificity in ERAD.